Evaluating Mitochondrial Quality Control in the Outflow Facility

PROJECT SUMMARY
This is a K08 Mentored Clinician Scientist Development Award application for Anh Pham, MD, PhD,
who is an Assistant Professor of Ophthalmology at the Bascom Palmer Eye Institute (BPEI) with a career
goal of becoming an independent clinician-scientist in the field of glaucoma. Her research focus examines
the metrics of mitochondrial health, including morphology, biogenesis, selective removal, and genomic
stability, in the outflow facility between healthy and glaucoma patients. The research proposal seeks to
identify mitochondrial dysfunction as an important mechanism for the development of ocular
hypertension. The long-term goal of this project is to acquire the scientific skills needed to enhance our
understanding of the regulatory mechanisms controlling mitochondrial health in the outflow facility and
to develop mitochondria targeted therapies to improve intraocular pressure homeostasis.
The scientific objective is to test the hypothesis that impaired mitophagy, the selective clearance
of damaged mitochondria, contributes to the accumulation of mitochondrial dysfunction in glaucoma
outflow facility. The project will utilize in vitro, ex vivo, and in vivo models of the outflow facility to
examine the intrinsic relationship between mitochondrial health and TM physiology. There are three
focused aims to test this hypothesis: 1) Compare mitochondrial function between healthy and glaucoma
TM in cell culture; 2) Simulate ocular hypertension in an ex vivo model to develop a tissue platform for
examining the protective effects of mitophagy induction in TM physiology; 3) Develop a mouse model
with mitochondrial dysfunction in the outflow facility as a potential model for aging in the eye and ocular
hypertension. Results of the proposed research will establish the foundation for an R01 application on
mitochondrial quality control in the anterior segment.
The career development objective is to develop the mentorship and expertise to become a
productive and independent clinician-scientist. Dr. Pham has assembled a mentorship team consisting of
Dr. Sanjoy K. Bhattacharya, an expert in TM biology and Dr. Carlos Moraes, an expert in in vivo models
of mitochondrial dysfunction. Additionally, she has identified key collaborators and consultants including
Drs. Felipe Medeiros, Richard K. Lee, Padmanabhan Pattabiraman, and Weiming Mao. She will meet
regularly with her mentors and advisors to discuss career development, attend pertinent university
seminars and workshops, present research annually at national conferences, consistently submit work for
publication, and apply for extramural funding. The extensive clinical and scientific resources at BPEI, the
world-class faculty on the mentorship and advisory committee, and the dedicated institutional
commitment will provide Dr. Pham with the support needed to promote scientific independence in the
study of mitochondrial health in the anterior segment.

Public health relevance
PROJECT NARRATIVE Older age and ocular hypertension are significant risk factors for the development of glaucoma, a leading cause of irreversible blindness in the United States and worldwide. Mitochondrial genetic and structural abnormalities have been documented in the outflow facility, the main site for aqueous humor drainage and maintenance of intraocular pressure. This study examines the quality control mechanisms that regulate mitochondrial health in the outflow facility to establish mitochondrial dysfunction as a cause for ocular hypertension and to identify potential candidates for improving control of intraocular pressure.